Pathophysiologic roles of protein-protein interactions at excitatory synapses and their modifications in schizophrenia

Abstract
Genome-wide investigations of genetics, epigenetics and transcriptomics have identified
hundreds of genetic variants playing etiologic roles in schizophrenia. Remarkably, pathway
analyses of various algorithms consistently point to the synapse and biological processes
therein as the most significant point of convergence. The next challenge is to find principles by
which these genetic variants and dysregulation of those gene products conspire to precipitate
synaptic pathology of the illness. NMDA receptor hypofunction underpins the synaptic
pathology of SCZ; yet its pathophysiologic mechanisms remain unknown. We propose that
defects in protein-protein interactions between key synaptic proteins drive NMDAR
hypofunction in SCZ. Consistent with this model our preliminary data indicate that two distinct
sets of protein-protein interactions are altered in SCZ. Previously, we found molecular evidence
for NMDAR hypofunction, i.e., reduced tyrosine phosphorylation of GluN2A (encoded by
GRIN2A) in schizophrenia. Subsequently this dysregulation was traced to hypoactivity of Src
kinase, which in turn resulted from altered protein association of Src with a number of signaling
partners. More recently, our preliminary studies showed that SCZ mutation of GRIN1 (encoding
GluN1), G386C , reduces GluN1-EphB2 association altering NMDAR mobility and that GluN1-
EphB2 association is reduced in patients. To test whether PPI might be an organizing principle
for NMDA receptor hypofunction, we will focus three specific aims to examine how the two
PPIs altered in SCZ impact nano-scale molecular events to cause NMDAR hypofunction and
how we might rescue these defects. The aims are: Aim 1: Determine nano-domain specific
spatial alterations in NMDAR complex proteins in SCZ. Aim 2. Delineate PPI alterations
in NMDAR complexes in SCZ and their rescue by activating Src kinase. Aim 3: Determine
the impact of SCZ mutations on the nano-organization of the spine synapse and their
rescue by leveraging altered PPIs in SCZ. Together, these aims will test the hypothesis that
the NMDAR protein-protein interaction network is a common pathway linked to SCZ
pathophysiology. This will likely define new avenues of investigation and understanding of the
cellular-molecularly mechanisms of SCZ and if successful, this work could identify NMDAR PPI
modulation as an important new strategy for modulating SCZ pathophysiology.

Public health relevance
Schizophrenia is manifested by deficits in multiple neuropsychological domains and altered activity of brain circuits which are driven by dysfunction of the synapse. As a critical knowledge gap, it remains unknown how disease-linked synaptic dysfunction arises. In this proposal we will determine the impact of synaptic schizophrenia risk genes on synaptic nano-architecture, protein interactions, and structural plasticity by focusing on how specific defects in protein-protein interactions impact synaptic organization.